Molecular and Genetic Analysis of Fin Regeneration in Zebrafish

ABSTRACT
Regenerative capacity is widespread across almost all animal phyla, but the distributing pattern appears
inexplicable. Teleost fishes and urodele amphibians can regenerate amputated appendages, such as fins and
limbs, whereas this ability is largely restricted to digit tips in adult mammals. This diverse regenerative distribution
raises questions about how animals evolve toward loss or gain of regenerative capacity. This proposal will use
zebrafish fins as a model to elucidate cellular and molecular mechanisms controlling regenerative ability. A
critical aspect of appendage regeneration is nerve dependence, as denervated appendages display impaired
regeneration phenotypes. Previous studies showed that upon injury nerves and their associated Schwann cells
provide trophic factors to drive appendage regeneration. However, the accurate reconstruction of nerves during
appendage regeneration and their target cells remain unknown. Moreover, the cellular and molecular
mechanisms governing production of neurotrophic factors and interaction between nerves and Schwann cells
remain elusive. Recent studies also revealed that sensory cells interplay with immune cells and nerves to
influence tissue homeostasis and regeneration. Yet, the cross-talks among neuro-immune-sensory cells for
appendage regeneration are unexplored. Our research programs will address these key questions in the field of
appendage regeneration by employing zebrafish genetic models combined with cellular, molecular, spatial
transcriptomic methodologies. First, we will elucidate cellular and molecular mechanisms underlying peripheral
nervous system reconstruction and neural modulation of fin regeneration. Second, we will dissect cellular and
molecular dynamics that enable special epithelial cells and their interacting partners to engage in neuro-immune-
epithelial interactions for fin regeneration. Third, we will utilize MERSCOPE to generate spatial maps detailing
the cellular and spatial remodeling processes underlying fin regeneration. The results of these research
programs will offer a comprehensive insight into the basic principles of appendage regeneration, providing new
avenues to study how innervation, immune cells, and local tissues drive appendage regeneration.

Public health relevance
NARRATIVE This work will establish an innovative, broadly applicable paradigm for how tissue regeneration occurs and how the nervous system affects peripheral tissue regeneration. This work will also discover crucial cell types and genes regulating tissue regeneration. The results from our studies lead to innovative strategies for treating tissue repair.